Experimental Therapeutics Program

The Experimental Therapeutics (ET) Program provides an organized integrated infrastructure that enables both
clinical translation of basic and population science research from Simmons Comprehensive Cancer Center
(SCCC) research programs and identification of clinically relevant hypotheses for testing by SCCC basic science
programs. The four program specific aims focus on therapeutic development and biomarker discovery, where
members work collectively to: (1) develop molecular therapeutic sensitizers by focusing on the development of
unique tumor-selective agents that enhance existing therapies, (2) target tumor microenvironment with
immunotherapy by modulating the role of immune cells in tumor progression, (3) advance imaging and drug
delivery by developing novel imaging and nanotechnology delivery platforms to enhance cancer diagnosis and
therapy, and (4) exploit cancer vulnerabilities by leveraging synthetic lethalities as new “targeted” therapy for
cancer. The ET Program brings together 78 SCCC members from six basic science and 12 clinical departments
comprising 44 NCI-funded projects, including two SPOREs and 14 multi-PD/PI awards. In response to evaluative
activities and strategic goals to facilitate collaborative translational research, ET recruited new senior clinical
researchers; expanded translational studies and investigator-initiated clinical trials (IITs) to include most cancer
types and to address the needs of the catchment area; enhanced interactions with SCCC members; integrated
radiation oncology faculty into the program; and improved the infrastructure and funding for IITs. ET members
participate in and lead multicenter IITs and they collaborate with pharma/biotech, which often leads to
investigator-initiated trials and translational studies. Importantly, the funded SPORE programs in kidney and lung
cancers and new SPORE applications in prostate and liver cancers are actively supported by ET member
expertise. The ET Program has expanded therapeutic pipelines in a majority of adult and pediatric cancers.
Highlighted successes include the in-house development and clinical translation of therapeutic strategies for
KRAS mutant cancers, HIF2alpha-targeting for kidney cancer, antagonists against mutant estrogen receptors in
breast cancers, strategies to activate the STING innate immune pathway, and clinical trials capitalizing on
synergy between stereotactic radiation therapy and immune checkpoint inhibitors. Future directions include
investment in preclinical models (spheroid/organoid cultures, humanized mice), precision oncology (customized
panels, SCCC molecular tumor boards, recruitment of a translational leader in genomic oncology), immuno-
oncology (immune profiling; novel PET tracers; systemic and organ-specific autoantibody biomarkers; expansion
of the innate immunity program), disease-focused translational research programs (recruitment of leadership in
breast, GI, lung, GU, neuro-oncology, hematologic malignancies, and Phase I programs); and expansion of
interactions with the Office of Community Outreach, Education & Equity in order to increase clinical trial accruals
across our catchment area and among the underserved.